Epidemiology and Biostatistics of Aging

? DESCRIPTION (provided by applicant): This is an application for a 5-year renewal of an institutional training grant in the Epidemiology and Biostatistics of Aging, funded by NIA since 1996. This multidisciplinary program's goals are to train outstanding predoctoral and postdoctoral candidates to lead the next generation of quantitative research scientists addressing the health of our aging population. This program is conducted jointly by epidemiologists and biostatisticians with a strong commitment to bringing together students in both disciplines to develop expertise in the content areas and methodologies that are essential to advancement of the field. Students are trained to conduct leading- edge research that can inform the development of prevention programs to compress morbidity in the aging population. The program is based in the Departments of Epidemiology and Biostatistics; beginning this cycle, the Department of Mental Health will join us as a third sponsor. It further involves faculty from departments throughout our Schools of Public Health, Medicine, and Nursing. A Program Director in Biostatistics, Co- Directors from Epidemiology and Mental Health, 6 other Associate Directors, and 22 other core faculty members will serve as mentors for the trainees. We propose to maintain our current program size of 8 predoctoral positions and 2 postdoctoral positions, in numbers balanced across sponsoring departments. We will support postdoctoral fellows at experience level 0, and for those with clinical backgrounds seeking advanced research degree training, level 5. We will target a 3-4 year duration for each pre-doctoral trainee and a two-year duration for each postdoctoral trainee. A core curriculum is expected of predoctoral trainees and customized to postdoctoral trainees. Trainees will continue to participate in biweekly research in progress meetings, seminars on aging, practica specific to this program, and training to build skills in multidisciplinary collaboration. Research experiences and mentors are selected to ensure high quality research worthy of peer- reviewed publication. We will continue to train students in epidemiologic and biostatistical methods and their application to aging, with emphases on the epidemiology of chronic disease, disability and frailty, biostatistics and translational research methods for gerontology, the psychosocial epidemiology of late life, and, new to this cycle, data-intensive measurement and analysis in aging. Trainees have been highly productive, gained substantial recognition for their research, and launched their careers in appealing positions with emphases on aging. Graduates will be effective leaders of multidisciplinary research teams tackling the health problems associated with the aging US population.

Public health relevance
PUBLIC HEALTH RELEVANCE: This program addresses a critical need of the field of gerontology for scholars who combine quantitative expertise with immersion in science on aging. Such scholars are crucial because cutting-edge research on aging involves complex data on persons' biological and clinical characteristics, physical and social environments, and health care utilization. Only with such scholars' leadership can data be collected and analyzed so as to yield valid scientific discoveries on improved outcomes for our older population.